Annual Health Services Research Meeting

AcademyHealth
Annual Research Meeting (ARM) Abstract
The AcademyHealth ARM is the principal dissemination conference for the field of health services
research. By convening more than 3,000 producers and users of health services research, the meeting
provides a vehicle to translate important health services research into health policy and practice. As
such, the meeting strives to synthesize, summarize, and communicate health services research findings
to a broad range of individuals and organizations that have the capacity to use the information to improve
health policy and clinical practice. The ARM also offers a broad range of professional development
opportunities for all levels of researchers.
The ARM objectives are to:
 disseminate the latest results of health services research;
 sharpen skills in research methods;
 ascertain new data and resources for conducting research and resources for researchers’
professional development;
 learn about research funding priorities of federal agencies and foundations;
 discuss policy issues critical to health services research and health care delivery; and
 network with colleagues of all levels in the fields of health services research and health policy.
The ARM objectives are consistent with AHRQ’s mission to “make health care safer, higher quality, more
accessible, equitable, and affordable…and to make sure that the evidence is understood and used.”
Conference sessions present research that can improve policy and practice, patient safety and quality,
patient-centered care, and payment and organization. The meeting also focuses on AHRQ’s priority
populations—low income groups, minority groups, women, children, the elderly, individuals with
disabilities and end-of-life care.
Now in its 37th year, the ARM is the premier forum for health services researchers and users of
research. Building upon past success, AcademyHealth, with the help of meeting stakeholders, will
continue to convene the field of health services research and translate its work into health care
improvement.

Public health relevance
AcademyHealth Annual Research Meeting Narrative AcademyHealth’s Annual Research Meeting (ARM) is the premier event for more than 3,000 health services researchers to disseminate their research and to enhance their careers by learning about new methods and networking with fellow researchers and users of their research. With 450 research presentations in sessions and 1,500 poster presentations, the ARM strives to synthesize, summarize, and communicate health services research findings to a broad range of individuals and organizations that have the capacity to use the information to improve health policy and clinical practice. The ARM’s objectives successfully complement and support AHRQ’s mission to improve the quality, safety, efficiency, and effectiveness of health care for all Americans.